PITUITARY FUNCTION AFTER VISION TRANS-SPHENOIDAL HYPOPHYSEAL SURGERY

Investigation of pharmacologic provocative and suppressive tests of hormones secreted by pituitary tumors, before and after transsphenoidal removal, for the purposes of diagnosis of tumor vs functional hypersecretion, as a test of completeness of removal, and to look for evidence of altered hypothalamic control after complete tumor removal.